Development and Validation of an Observational Rating System for Individual Tailoring in Family-Based Pediatric Obesity Interventions

Project Summary/Abstract
Pediatric obesity is a public health crisis associated with costly cardiovascular and chronic diseases and
decreased quality of life. A disproportionate number of children with obesity, defined as a body mass index
(BMI)≥95th percentile for age and gender, are racial/ethnic minorities or socioeconomically disadvantaged.
Family-based treatments for childhood obesity have demonstrated effectiveness but struggle with high
participant drop-out and inconsistent attendance, limiting opportunities for intervention effects and improving
health outcomes. Caregivers frequently drop out due to a program overloading irrelevant information or not
meeting their expectations. Due to the complexity of pediatric obesity, contributors to children's weight gain can
greatly vary from family to family. Individually tailored family-based programs use rigorous assessment to
develop individualized treatment plans that address a family's unique needs and treatment priorities. The
Family Check-Up 4 Health (FCU4Health) is an assessment-driven individually tailored family-based pediatric
obesity program that targets parenting skills and health behaviors and has had high rates of participation and
retention among a low-income predominantly ethnic minority sample. Despite the promise of individual
tailoring, tools to quantify the process of individual tailoring are understudied, hindering the ability to evaluate
individual tailoring and analyze the theory that tailoring affects program engagement and outcomes. The
proposed study will develop and validate an observational rating system to measure the process and degree of
individual tailoring in family-based pediatric obesity interventions. Videorecorded sessions, transcripts and
multimethod data from a completed trial of the FCU4Health, the Raising Healthy Children (RHC) project, will be
used to develop the observational rating system. Next, a second trial of the FCU4Health, the Healthy
Communities 4 Healthy Students (HC4HS) project, will be used to validate the new rating system. Finally,
scores from the new rating system will be used to test the relationship between individual tailoring, program
engagement and changes in health behaviors and anthropometric outcomes using a combined RHC and
HC4HS sample. This novel research will employ video observation coding, psychometrics, structural equation
modeling, and implementation science methods. The new tool will advance the field of pediatric obesity
research by providing a rating system to guide the design, implementation, and evaluation of pediatric obesity
interventions with an individual tailoring component. Quantifying individual tailoring will elucidate its relationship
with program engagement and outcomes to inform adaptations for evidence-based interventions. The
enhanced interventions will accommodate participants' needs, facilitate health behavior change and ultimately
prevent and manage pediatric obesity and reduce risk for associated diseases.

Public health relevance
PROJECT NARRATIVE Individually tailored family-based pediatric obesity interventions are hypothesized to engage families and promote health behavior change but there is no standardized tool to measure the “individual tailoring” component to demonstrate these relationships. The proposed research will develop and validate an observational rating system to quantify the process and degree of individual tailoring and their associations with intervention engagement and health outcome variables. The new rating system developed in this study will be extended to improve program development, implementation and evaluation and enable new research to attenuate the pediatric obesity epidemic and its abundance of associated cardiovascular and chronic diseases.